Understanding spinal neuropeptide signaling in itch

PROJECT SUMMARY/ABSTRACT
Chronic itch disorders are the primary reason for visits to dermatologists and have devasting effects on patient
quality of life. Despite extensive research efforts, an effective treatment for chronic itch remains elusive, in part
because the basic neural coding that underlies itch is poorly understood. The long-term goal of the investigator’s
research program is to elucidate the neural mechanisms that underlie processing of itch input under normal and
pathological conditions. Interestingly, one hallmark of chronic itch disorders is the upregulation of excitatory
neuropeptides that drive itch – substance P (SP) and gastrin-releasing peptide (GRP) – within the spinal cord.
However, the mechanism by which neuropeptides modulate spinal circuits to produce itch is unclear. To address
this fundamental gap in knowledge, this proposal will investigate whether neuropeptides (SP and GRP) act in
parallel with neurotransmitters (on the same targets) or if neuropeptide signaling diverges from
neurotransmission (engage distinct targets), thereby reconfiguring spinal circuits. Specifically, the investigator
will test the hypothesis that the itch-inducing neuropeptides SP and GRP act via divergent signaling to
reconfigure neural circuits in acute and persistent itch. During the K99 Phase, she will learn and apply cutting-
edge approaches that span from the neuron ultrastructural to population level. Aim 1 (K99) will compare spinal
synaptic connectivity to neuropeptide connectivity using multiplexed electron microscopy. Aim 2 (K99) will
identify the spinal networks activated by neuropeptide versus synaptic transmission from SP (and GRP) spinal
neurons using two-photon Ca2+ imaging in combination with an ex vivo somatosensory preparation. A portion of
the K99 phase will also be dedicated to learning to implement machine learning algorithms to detect and quantify
mouse itch behaviors, and to career development activities such as gaining leadership and mentorship skills and
presenting at conferences to expand the applicant’s professional network. Aim 3 (R00) will determine whether
the SP and GRP signaling are required for the manifestation of aberrant spontaneous spinal cord activity (Aim
3A) and elevated itch behaviors (Aim 3B) associated with persistent itch using pharmacological inhibition
strategies. These studies will leverage her new expertise in two-photon Ca2+ imaging and automated behavioral
analysis pipelines developed during the K99 phase in combination with her strong background in rodent itch
models. Together, these experiments will provide fundamental insights into neuropeptide signaling in spinal itch
transmission and identify the necessity of spinal neuropeptide signaling in persistent itch. The success of this
career award training plan, which includes activities for scientific and career development, will be aided by the
scientific expertise, collaboration, and educational opportunities offered by the Pittsburgh Center for Pain
Research. Completing this plan will prepare the applicant to lead an innovative research program as an
independent investigator.

Public health relevance
PROJECT NARRATIVE Chronic itch is prevalent and devasting condition that lacks an effective treatment, in part because the basic neural coding that underlies itch is poorly understood. The goal of this proposal is to determine how neuropeptides influence the coding of itch in the spinal cord under normal and persistent itch conditions. This research will provide basic insights into the role of neuropeptide signaling in itch and inform the development of novel therapeutics for chronic itch.